SARS-CoV-2 Assessment of Viral Evolution

This work will facilitate rapid global data sharing about SARS-CoV-2 variants of concern (VOCs). This agreement will support three research projects designed to help monitor and evaluate SARS-CoV-2 genome evolution and characterize variant viruses.